U.W. Radiological Sciences Training Program

[unreadable] DESCRIPTION (provided by applicant): This training program prepares predoctoral graduate students and postdoctoral researchers for careers in the application of physics to the medical diagnosis and treatment of cancer. Available research specializations encompass all areas of physics support for patient treatment, disease diagnosis, and basic physics research applied to cancer. Trainers in the Department of Medical Physics, Radiology, Human Oncology (Radiation Oncology), Oncology, Engineering Physics, and Bio-medical Engineering maintain a broad spectrum of research collaborations with other clinical and basic science researchers. Translational, team driven research includes radiation therapy and radiation biology with the Department of Oncology, traditional x-ray, digital, CT, MRI, ultrasound, and PET imaging with the Department of Radiology, and radiation physics with the Departments of Physics and Nuclear Engineering. Trainees are intimate participants in these research programs as collaborators, publishing joint research articles, and performing as investigators in extramurally funded grants and contracts. Extensive faculty contact provides leadership and supervision. Beyond research activities and minor subject requirements, predoctoral trainees as graduate students in Medical Physics take at least twenty-seven credits supportive of medical physics training and oriented towards their research specialization. Postdoctoral trainees are encouraged to broaden and deepen their academic training by auditing appropriate courses. Trainees give seminars, attend colloquia, and present research results at local, national, and international meetings, and co-author articles and reports. An annual training grant symposium provides additional opportunity for trainees to present research results to the Medical Physics and collaborating faculty. In this way, trainees of this program are well prepared to assume leadership positions as researchers and academicians in the application of physics to cancer treatment, diagnosis and prevention. [unreadable] [unreadable]